A Rapid HIV RNA Detection without Sample Preparation

A Rapid HIV RNA Detection without Sample Preparation
CrossLife Technologies Inc.
Project Summary/Abstract
Early diagnosis of new infections and detection of emergence of viral rebound for individuals
on treatment hold the key to effective management of HIV. Among many diagnostic
approaches, self-testing has become increasingly acceptable in recent years, but
immunoassay-based home tests are insufficiently sensitive for early diagnosis and
incompatible with treatment monitoring. In this project, we propose to develop a rapid,
sensitive, specific, simple, and cost-effective diagnostic technology for RNA detection in
unprocessed blood samples. The proposed technology features unique chemistry innovations
in biomolecular assays (TARA) and our ability in integrating and automating these innovations
onto simple devices with precisely time-gated steps. The R61 phase (Aims 1-3) focuses on
technology development, integration, and optimization; and the R33 phase (Aims 4-5) focuses
on technology validation using archived samples and prospective clinical samples. These
specific tasks will be carried out by a highly multidisciplinary team with well-established
collaborations and complementary expertise. If successful, the test kit will enable diagnosis
and viral load monitoring by individuals in their home or in a pharmacy and be appropriate for
minimal-resource settings where HIV is most prevalent. Sensitive diagnosis and monitoring
enable earlier treatment and reduce HIV transmission.

Public health relevance
A Rapid HIV RNA Detection without Sample Preparation CrossLife Technologies Inc. Narrative We propose to develop a rapid, sensitive, specific, simple, and cost-effective diagnostic – “TARApen” – by integrating innovations in biomolecular recognition (TARA) and microfluidic design that address the key limitations of current home-test kits. The resulting TARApen test will automate all steps of molecular analysis and amplification for detection of HIV RNAs in blood finger-stick without sample preparation.